Acute kidney injury-associated delirium after cardiac surgery

Our mechanistic understanding of delirium after cardiac surgery (CS-Delirium) is limited and few
pharmacologic treatments exist. Acute kidney injury (AKI) is a strong risk factor for delirium. However, in the
cardiac surgery patient population, the incidence of AKI-associated delirium (CS-AKI-Delirium) and the risk
factors for CS-AKI-Delirium are unknown. Our preliminary data suggest that the CS-AKI-Delirium subgroup
accounts for 55% of CS-Delirium patients, develops a unique intraoperative cytokine and chemokine profile,
and develops higher intraoperative endothelial activation than the non-AKI CS-Delirium subgroup. Further, our
data suggest that an association between higher intraoperative endothelial activation and a greater odds of
delirium exists only in the CS-AKI-Delirium subgroup. We hypothesize that CS-AKI and CS-Delirium are
mechanistically linked by systemic inflammation and endothelial activation in the CS-AKI-Delirium subgroup. If
data supporting a linked mechanism were generated, these data would rapidly advance the study of CS-
Delirium by facilitating the translations of a portion of CS-AKI mechanistic knowledge and therapeutic targets to
CS-AKI-Delirium. We propose the first prospective study of CS-AKI-Delirium, involving 300 adults undergoing
on-pump coronary artery bypass surgery. This study will determine the incidence and clinical phenotype of CS-
AKI-Delirium (Aim 1), delineate signaling pathways composed of intracellular and extracellular mediators of
inflammation and endothelial activation associated with CS-Delirium and CS-AKI-Delirium specifically (Aim 2),
and test the hypothesis that higher endogenous high-density lipoprotein capacity to suppress endothelial
activation is associated with less CS-AKI and less CS-AKI-Delirium (Aim 3). During this study, inflammatory
signaling pathways will be characterized using comprehensive and complementary methods including high
throughput biomarker analysis of plasma collected before and after surgery, and total RNA sequencing, RNA in
situ hybridization, and immunohistochemical staining of ascending aortic tissue collected during surgery. Our
research team has over 70 years of combined experience identifying and deeply characterizing such
pathways. The innovation of this proposed study is the recognition that CS-AKI and CS-Delirium may not be
independent postoperative co-morbidities, but instead may be mechanistically linked disease states in a large
subset of CS-Delirium patients. Data generated in this study about the incidence of CS-AKI-Delirium and the
statistical tool developed during this study to identify this patient subgroup will facilitate designing and powering
future CS-AKI therapeutics trials to add CS-AKI-Delirium as a secondary endpoint if scientifically justified. This
single change in scientific thinking and addition of our clinical study data to the field of CS-Delirium could
increase the number of CS-Delirium therapeutic trials many-fold in a highly-cost effective manner. Our
research team has over 25 years of combined experience performing prospective observational studies of AKI
and delirium at the proposed study site and is highly qualified to complete this proposed study.

Public health relevance
The incidence and clinical characteristics of patients who develop acute kidney injury-associated delirium after cardiac surgery (CS-AKI-Delirium) is unknown, however our preliminary data suggest that patients who develop CS-AKI-Delirium account for 55% of delirium cases after cardiac surgery, and that these patients develop a unique intraoperative cytokine and chemokine profile and higher intraoperative endothelial activation compared to non-AKI delirium patients. We hypothesize that acute systemic inflammation and endothelial activation are a common mechanism underlying the development of AKI and delirium after cardiac surgery. We propose a 300 patient prospective observational study to determine the incidence and clinical phenotype of CS-AKI-Delirium (Aim 1), to delineate signaling pathways composed of intracellular and extracellular mediators of inflammation and endothelial activation associated with CS-Delirium and CS-AKI-Delirium specifically (Aim 2), and to test the hypothesis that higher endogenous high-density lipoprotein capacity to suppress endothelial activation is associated with less CS-AKI and less CS-AKI-Delirium (Aim 3).